Polypoid cell cycle regulation and genome instability

SUMMARY
Cell division and stress response differ among tissues and are perturbed in disease. This proposal focuses on
a variation called the endocycle, during which cells periodically replicate their DNA without dividing, resulting in
an increase in cell size and cellular DNA content (polyploidy). This alternative growth program occurs widely in
nature, including many tissues in humans (e.g. liver, heart, blood, skin). Emerging evidence indicates that cells
also switch to endocycles during wound healing, regeneration, and cancer. Despite their importance, much
remains unknown about how endocycles are regulated and how they contribute to tissue growth and disease.
The objectives of this proposal are to define the molecular and cellular mechanisms that regulate endocycles,
their modified response to DNA damage, and their contribution to genome instability and cancer. Our previous
studies showed that endocycling cells in the fruit fly do not undergo programmed cell death (apoptosis) in
response to radiation or other treatments that damage DNA, a property that others have shown is shared by
endocycling cells in mice. The repression of cell death acts through chromatin silencing of target genes of the
p53 tumor suppressor. Our previous studies also showed that both fly and human cells can be induced to
switch to endocycles, and then can switch back to mitotic divisions that are extremely error prone, resulting in
daughter cells with abnormal DNA content (aneuploidy). It is known that human cancer cells are frequently
aneuploid and that tumors contain giant polyploid cells. Together, these observations lead to the hypothesis
that a transient switch to endocycles leads to cancer cell survival with a return to mitosis causing mutations
that promote cancer progression. This proposal seeks to understand the molecular mechanisms that regulate
endocycles, repress apoptosis, and contribute to tumor formation and metastasis. We will use the powerful
tools in the fruit fly to achieve three specific aims: 1) To determine how the repression of apoptosis is linked to
the endocycle program, 2) To define the mechanism by which CycA / CDK activates the Myb-MuvB to regulate
alternative cell cycle programs, 3) To determine the contribution of transient endocycles to oncogenic growth
and metastasis. The outcomes of this proposal will fill a major knowledge gap in understanding the regulation
of the variant endocycle growth program and its contributions to development and cancer, ultimately leading to
better regenerative medicine and cancer therapies.

Public health relevance
NARRATIVE How cells divide, grow, and respond to stress differs among tissues and is perturbed in disease, but the molecular mechanisms for these variations remain incompletely understood. This proposal seeks to fill this knowledge gap for the endocycle, a variant growth program that contributes to normal tissue growth and cancer. The long-term outcomes will have a major positive impact on human health through development of new therapies for regenerative medicine and cancer.